National Environmental Health Association (NEHA) Body Art Training Updates and Delivery

Project Abstract
The National Environmental Health Association (NEHA), a 501(c)3 non-profit organization, is
pleased to apply for funding assistance under the U.S. Food and Drug Administration (FDA)
Support for Conferences and Scientific Meetings (R13 Clinical Trial Not Allowed), FOA Number:
PAR-19-306.
NEHA proposes to continue the development and delivery of the pilot Body Art Facility Inspector
Training, tailored to environmental health (EH) professionals responsible for inspecting body art
establishments. Over a five-year period, NEHA will host workshops to evaluate and update the
course content and delivery based on subject matter expert (SME) guidance and participant
evaluations. NEHA will incorporate updates into training materials and deliver the course annually
at its Annual Educational Conference (AEC). During the third year, NEHA will convert the
awareness level course into a virtual, asynchronous training to expand access to the training and
accommodate the varying needs of the EH workforce. NEHA will continue to deliver the course
in-person at the AEC while pivoting the development process to an operations level training.
Through the collaboration between NEHA, the Association of Food and Drug Officials (AFDO),
and the Body Art Education Alliance (BAEA), the Body Art Training Development Workshops will
build upon years of cooperative work to further develop the knowledge, skills, and abilities of the
EH workforce.

Public health relevance
Project Narrative Body art has experienced a steady increase in popularity in the U.S., leading to many jurisdictions rapidly enacting new regulations. Environmental health professionals are responsible for inspecting facilities to meet regulatory requirements, but there is a proven lack of comprehensive education and training, making inspections a learn-as-you-go process. The proposed Body Art Training Development Workshops, utilizing industry knowledge and regulatory experience, will develop training programs to provide a consistent, informed approach to the inspection of body art facilities.